Molecular Mechanisms of V-ATPases: Assembly, Biogenesis, Regulation, and Function

Summary
Vesicular- or vacuolar-type adenosine triphosphatases (V-ATPases) are multi-component, ATP-driven proton
pumps consisting of a V1 complex that possesses ATPase activity and a Vo complex for proton transfer across
the membrane. V-ATPases play important roles in the acidification of intracellular vesicles, organelles, and the
extracellular milieu, and are essential for maintaining the pH homeostasis of endosomes, lysosomes, and the
Golgi apparatus in all eukaryotic cells. V-ATPase deficiency in mammals is embryonic lethal, and malfunction of
V-ATPases is associated with numerous diseases, including microbial infection, renal tubular acidosis,
osteoporosis, sensorineural deafness, neurodegenerative diseases, and cancer. Despite the critical functions of
V-ATPases, we have limited understanding on the biogenesis, assembly, regulation, and signaling of mammalian
V-ATPases. A major challenge in studying mammalian V-ATPases is that the pure complexes are difficult to
obtain for biochemical and biophysical experiments. We developed an innovative method to purify large amounts
of human V-ATPase to homogeneity directly from cells. Our preliminary cryo-electron microscopy (cryo-EM)
structures of human V-ATPases show three functional states at up to 3.1 Å resolution and with all known subunits,
which together represent the most complete mechanistic model of V-ATPase to date. Our study revealed that
mammalian V-ATPases are composed of proteins, glycans, glycolipids, and lipids. Therefore, we defined the V-
ATPase as a glycoproteolipid complex. Our study opened up the field for comprehensively understanding the
biogenesis, assembly, regulation, and signaling of V-ATPases. Based on our prior work, we will complement
cryo-EM structure determination with biochemical and functional assays, yeast genetics, and mass spectrometry
analysis to address fundamental questions in the field, including the roles of glycolipids in the V-ATPase
assembly and function, the regulation of V-ATPases by reversible assembly, the detailed mechanism of proton
transfer, and the mechanisms of V-ATPase mediated cell signaling. The completion of this project will not only
provide conceptual innovations regarding the V-ATPases assembly, regulation, and signaling, but also inspire
new therapeutic strategies for treating V-ATPase-related diseases.

Public health relevance
Narrative The vacuolar ATPases (V-ATPases) are large, multi-subunit proton pumps that are essential for many fundamental physiological processes in all eukaryotic organisms and malfunction of V-ATPases is associated with devastating human diseases including cancer, renal tubular acidosis, osteoporosis, diabetes, neurodegenerative diseases, and AIDS. Elucidating the structures and molecular mechanisms of V-ATPases assembly, biogenesis, regulation, and signaling will greatly advance our understanding of these V-ATPase-associated diseases. The completion of the project will not only advance our understanding on V-ATPases but also offer mechanistic insights to modulate human V- ATPase activity for disease treatment.